Histone chaperones and cell state regulation

PROJECT SUMMARY
Homeostasis represents an essential balance between adjusting to changing conditions and maintaining overall
stability, with perturbations contributing to diseases including diabetes, pancreatitis and cancers. Epigenetic
mechanisms are central to homeostasis, including histone variants and the chaperone complexes that mediate
their deposition. Histone 3.3 (H3.3) is a replacement variant for canonical histone H3 and is deposited in
heterochromatin by a complex containing DAXX and ATRX. The importance of this epigenetic regulatory axis is
emphasized by the early embryonic lethality of mice when any component is deleted, along with recurrent
somatic mutations in human cancers. This includes mutually exclusive loss-of-function mutations in DAXX or
ATRX in 43% of pancreatic neuroendocrine tumors. The understanding of the physiologic functions of this
regulatory complex and its component parts remains in its infancy. Emerging evidence indicates individual
components regulate cellular differentiation states, including contributing to the establishment and maintenance
of induced pluripotent stem cells in vitro and safeguarding hematopoietic stem cells against inappropriate
differentiation in vivo. Recent work by the PI demonstrates that Daxx restricts cellular plasticity in the pancreas
and maintains endogenous retroviral (ERV) silencing in vivo. This leads to the central hypothesis of the proposed
research: As a regulator of H3.3 and heterochromatin, Daxx enforces a robust chromatin landscape that is
important for the maintenance of transcriptional states and differentiation programs. The proposed studies in this
project will combine comprehensive molecular and cellular analysis to dissect how this complex regulates the
epigenome, impacts gene expression, and contributes to physiologic cell state. To interrogate the requirements
for specific protein:protein interactions, two new mouse models have been generated that abrogate the Daxx:Atrx
and Daxx:H3.3 interactions respectively. These models will be used to: Define the specific contributions of Atrx
and H3.3 to Daxx-dependent regulation of the epigenome in vivo (Aim 1); and determine the requirements for
Atrx and H3.3 in Daxx-dependent regulation of pancreatic cell state in vivo (Aim 2). As mounting data suggests
ERV repression is an important physiological function of Daxx and acknowledging the differences in repeat
genomes between species, the proposed work will determine how DAXX loss affects transcriptional and cell
state programs in the context of a human genome (Aim 3). Collectively, this project proposes an innovative
research program that integrates powerful genetic models, in vivo structure-function analysis and comprehensive
epigenomic and transcriptomic profiling to provide direct mechanistic insight into how the Daxx/Atrx/H3.3
complex contributes to chromatin maintenance and dynamics, and how specific perturbations impact
downstream transcriptional and phenotypic states. Collectively, this work contributes to the project’s long-term
goal of understanding the molecular mechanisms that maintain cellular identity and homeostasis, and the
downstream pathological consequences when these mechanisms are lost.

Public health relevance
PROJECT NARRATIVE Understanding diseases, including diabetes, pancreatitis, and cancers, requires a comprehensive knowledge of how cells and tissues normally respond to stress to maintain stability. Important aspects of this are controlled by the organization and structure of the DNA within cells. We will study this biology and the important downstream (and potentially pathogenic) consequences when this normal regulation is lost.